Advanced Mass Spectrometry Facility

Principal Investigators reported that during the 2009 fiscal year 77 federal research projects overseen by 38 principal investigators were supported by the facility. Of this total 48 projects (62%) and 23 PI's(60%) were from NIDDK, 29 projects and 15 PI's were from other parts of NIH (NIAID 16-8,NIAMS 1-1,NIDA 6-1,NCI 2-1,NHGRI 1-1, NIDCR 1-1), and 1 PI and 1 project was from the FDA. One project (from Wei Yang, NIDDK) is excluded because a technical problem prevented the facility from providing analysis good enough to be considered support. One non-NIDDK PI (Martin Brechbiel, NCI) used the facility in FY2009 but has switched to NCI resources as a result of the reduced resources and staff time available for problematic non-NIDDK work. Although useful metrics for some things the PI-count and project-count are an oversimplification. It is important to note that the amount of support provided to each project varies widely. For instance support of small molecule chemists at NIDDK and a number of projects involving biopolymer analysis at NIDDK were very involved while most of the support provided to non-NIDDK labs involved one or two low staff time experiments. Support of Kenner Rice (NIDA) is a special case as he only recently move to NIDA from NIDDK and has had a long-standing working relationship with the facility in all its historical forms. Please see the individual research reports indexed here to learn more about the facility's role and the important research it supports. NIDDK Daniel Appella DK031119-05 Chemically Modified Peptide Nucleic Acids DK031123-05 Small Molecule Activators of p53 DK031124-05 Selective Recognition of Folded RNA by Small Oligomers Ad Bax DK029047-03 Structure and membrane binding of alpha-synuclein DK069017-02 Study of hemagglutinin membrane fusion domain DK075024-01 Study of the HIV integrase catalytic core domain and inhibitor binding Harris Bernstein DK052036-03 Translational regulation in the ribosome tunnel Carole Bewley DK031135-03 Discovery of Natural Products and Natural Product-Like Inhibitors* DK032103-10 Inhibitors and Probes of HIV-1 Cell Fusion* DK031136-03 Inhibitors of Mycothiol-Associated Enzymes* Susan Buchanan DK011010-02 Structural characterization of energy transduction by Tol proteins DK011011-02 Structural characterization of outer membrane proteins from Yersinia pestis Daniel Rafael Camerini-Otero DK052031-03 The role of Spo11 in mammalian meiosis DK052032-03 Proteins and the search for homology in mammalian meiosis Marius Clore DK029023-19 Structure and dynamics of macromolecules in solution by NMR DK029038-03 Design of gp41 directed anti-HIV antibodies* Chuxia Deng DK056010-03 BRCA1, DNA damage response and aging William Eaton DK029010-37 Ultrafast Protein Folding DK029055-03 Single Molecule Studies of Protein Folding DK029056-03 Physical Properties of Islet Amyloid Polypeptide John Hanover DK060101-03 Targeted disruption the enzymes of O-GlcNAc cycling DK060103-03 Enzymes of O-GlcNAc cycling linked to type-2 diabetes and neurodegeneration Jenny Hinshaw DK060100-14 Structure And Function Of Dynamin, A 100kd GTPase Involved In Endocytosis James Hurley DK036126-03 Structural and Functional Studies of Ubiquitin Binding Domains DK036127-03 Mechanisms of Diacylglycerol Signaling Through C1 Domain Proteins Kenneth Jacobson DK031115-26 Functionalized Congeners of Bioactive Compounds DK031116-22 Development of P2Y Receptor Ligands DK031117-22 Development of Drugs Acting at Adenosine Receptors DK031127-03 Development of Drugs Acting at Ion Channels Alan R. Kimmel DK075040-01 Signaling Pathways In Control of Growth and Development Paul Kovac DK059701-36 Reactions and Immunochemistry of Carbohydrates Constantine Londos DK015505-32 Regulation of neutral lipid metabolism in adipocytes and other cells. Hans Luecke DK069013-02 Chemical Probes of Gene Regulatory Mechanisms DK059702-03 Synthesis and Characterization of Selective Histone Acetyltransferase Modulators DK059703-03 Chemical Genetic Elucidation of Histone Acetyltransferase Signaling Networks Kevin O'Connell DK024151-07 Centrosome Maturation and Duplication in the C. elegans Embryo William Prinz DK060105-03 Biogenesis of the endoplasmic reticulum DK060004-08 Intracellular Lipid Trafficking and Organelle Biogenesis Herbert Tabor DK024961-03 LBG: Physiologic Functions of Polyamines DK024709-28 LBG: Polyamine Biosynthesis And Metabolism DK024960-03 LBG: Biophysical studies on the interaction of antizyme and ornithine decarboxylase John Tisdale (section viewed as NIDDK for facility purposes) HL006009-02 Isolation, characterization, and transplantation of candidate stem cells Robert Tycko DK029061-03 Structural Studies of Alzheimer's beta-Amyloid Fibrils DK029062-03 Structural Studies fo Amylin Fibrils Associated with Type 2 Diabetes DK029063-03 Investigations of Protein Folding by Solid State NMR DK075031-01 Structural Studies of Prion Fibrils and Other Protein Fibrils DK029063-03 Structural Studies of HIV-1 Proteins by Solid State NMR Reed B. Wickner DK024949-03 Structure of Prion Amyloids DK075018-01 Structures of non-prion amyloids DK024950-03 Biological Roles of Yeast Prions NIAID Dr. Clifton E. Barry III AI000693-15 Development of New Chemotherapeutics for Tuberculosis Thomas M. Kristie AI000711 HCF-1, A Mammalian Factor Controlling HSV Gene Expression AI000712 Regulation Of Transcription Of Herpes Simplex Virus Stephen Leppla AI000929-0608 Vaccines and Therapeutics for Anthrax AI001030-0108 Molecular Genetics and Pathogenesis of Anthrax AI001031-0108 Structure and Function of Virulence Factors of Bacillus anthracis AI001032-0108 Pathophysiological Actions of the Anthrax Toxins Michael Lenardo AI000565-13 LI-Regulation of signaling pathways involving nuclear factor kappa b AI000718-15 LI-Molecular Pathways of Programmed Cell Death and Viral Cytopathicity AI000769-13 LI-Molecular Mechanisms Of The Autoimmune Lymphoproliferative Syndrome Eric O. Long AI000525-22 Molecular Analysis of Human Natural Killer Cells Bernard Moss AI000307-28 Poxvirus Gene Expression AI000539-22 Poxvirus Entry AI001074-02 Poxvirus Assembly Helen Su AI001059-02 Defining New Human Immunodeficiency and Immunodysregulation Disorders Tsan (Sam) Xiao AI000960-03 Structural Studies of Pattern Recognition Receptors NCI Martin Brechbiel SC006353-25 ROB Metal Chelate Conjugated Monoclonal Antibodies for Tumor Diagnosis and Therapy SC010051-12 ROB Metal Chelate Conjugated Dendrimer Constructs for Diagnosis and Therapy NIDA Kenner Rice DA000527-02 Medicinal Chemistry of Drugs Acting on Central and Peripheral Opioid Receptors DA000528-02 Medicinal Chemistry of Drugs Acting on CRH Receptors DA000529-02 Medicinal Chemistry of Hallucinogenic Drugs DA000530-02 Medicinal Chemistry of Drugs Acting on Toll-like Receptors DA000531-02 Medicinal Chemistry in the Study of Alcohol Abuse DA000532-02 Medicinal Chemistry of Drugs Acting on Biogenic Amine Receptors NHGRI Christopher P. Austin HG200319-06 NIH Chemical Genomics Center NIAMS Robert Horowits AR027014-18 Molecular Mechanisms Of Myofibril Assembly And Function NIDCR John Thompson DE00341-28 Regulation of of Sugar Transport and Metabolism in Oral Bacteria NIAMS Robert Horowits AR027014-18 Molecular Mechanisms Of Myofibril Assembly And Function NIMH Howard A. Nash MH002228-24 Genetic Neurobiology of Drosophila Non-NIH, U.S. Government FDA Emily Shacter Project Number: 1016(OBP/CDER/FDA) Chronic inflammation, Apoptosis, and Cancer